Listening while wearing hearing protection: performance dynamics, choice to wear, and impacts of training

The Burden of occupational hearing loss (HL) is severe, having negative impacts on health care costs and
quality of life. There is a strong Need to address barriers to wearing hearing protection devices (HPDs) that can
prevent HL. This is especially true in regard to: (1) listening performance decrements that occur while wearing,
and (2) the operational environments of first responders whose workplace conditions allow relatively little
control over noise. This project will characterize HPD-related performance decrements, their impact on choice
to wear HPDs, and how auditory training can be used as a means to alleviate decrements.
Our innovative approach will use a paradigm where speech informs subjects to perform specific
aspects of a sensorimotor task. This mimics critical communication scenarios in first responders (e.g., a
firefighter given speech commands that inform her/his performance on another task). HPD listening will be
simulated with a digital filter designed to mimic the attenuation profile of an actual HPD.
Electroencephalographic (EEG) data will allow covert examination of neural signatures of ongoing cognitive
processes. The approach will allow the characterization of HPD-related performance effects to a level of detail
not achieved before, while at the same time maintaining research-to-practice relevance in the mapping of our
experimental task to first responder operational situations.
AIM 1 will characterize HPD-related decrements in performance. We expect that comparison of HPD
and no HPD conditions will reveal the extent to which HPD use impacts multiple dimensions of performance
(e.g., speech comprehension, sensorimotor task accuracy, and mental effort). AIM 2 will determine whether or
not performance decrements impact choice to wear HPDs. Here, we will allow subjects to voluntarily toggle
their simulated HPD on and off, while at the same time manipulating performance incentives to examine how
listening difficulty impacts time spent "wearing" hearing protection. AIM 3 will test an auditory training
approach to alleviating performance decrements. Here, we will compare effects of auditory training in HPD
and no HPD conditions on multiple dimensions of performance. Aim 1 Impact will be in knowledge gains that
cannot come from standard survey and focus group methods. The Impact of Aim 2 will be to provide an
assessment of how performance decrements impact actual choice to wear. The Impact of Aim 3 will be to
provide a means to address performance decrements in HL prevention programs (HLPPs).
Relevant NIOSH strategic goals include goals to: "reduce occupational hearing loss", and inform
"hearing loss prevention education for employers and workers". NORA sector groups of public safety,
construction, and manufacturing have clear relevance. Outputs include publications and conference
presentations at interdisciplinary venues that will accelerate research-to-practice directions. Outcomes entail
new approaches to addressing HPD use rates, and eventually, reduced occupational HL.

Public health relevance
Project Narrative Occupational hearing loss (HL) is a burden in regards to health care cost, worker performance, and quality of life. Hearing protection can prevent hearing loss, but workers often choose not to wear it because of listening difficulties that arise while wearing. This project will measure these difficulties, their impact on choice to wear HPDs, and test an auditory training approach to alleviating them.